CORE--COORDINATING CORE

Core Unit C is responsible for coordinating essential aspects of both basic and clinical research and for the productivity of projects that depend upon either cultured type II pneumocytes or the entry of human subjects (i.e., premature infants) in clinical protocols. This Core will provide centralized research support services in an efficient, cost-effective fashion--allowing investigators to optimize their efforts with individual and collaborative research projects. Core Unit C will serve all four research projects with highly skilled personnel such as a pediatric research nurse and a dedicated cell culture technician--thereby facilitating the scientific efforts of all responsible investigators.